Bacterial adaptions in host-microbe interactions.

PROJECT SUMMARY/ABSTRACT
Inflammatory bowel disease (IBD) has long been associated with compositional and metabolic changes in the
gut microbiota, yet extensive research efforts have failed to identify a single pathogenic microorganism as the
causative agent. In this grant, we investigate an alternative hypothesis in which gut inflammation drives
adaptations in commensal bacteria that further exacerbates disease in IBD. Though bacterial adaptations are
necessary for commensal survival and persistence in the inflamed gut, we currently do not understand how these
adaptive strategies alter the function of commensal microbes. These include metabolic and immunomodulatory
activities of commensal bacteria that regulate mucosal immune homeostasis in health and disease. Thus, there
is a critical need to understand how the inflamed gut environment shapes commensal bacteria metabolism to
further exacerbate inflammation in IBD. The long-term goal of this study is to understand how gut bacteria direct
immune responses in order to develop rational microbial therapies for inflammatory diseases. Our central
hypothesis is that the oxygenated environment of the inflamed gut drives metabolic adaptations in commensal
bacteria, resulting in expansion of bacterial strains that exacerbate intestinal inflammation. The central
hypothesis will be tested by pursuing three specific aims: 1) define the genetic and functional variation of
commensal Bacteroides fragilis in the IBD gut; 2) determine the metabolic adaptations of commensal bacteria
during experimental colitis; and 3) identify the impact of oxygen on anaerobic bacterial metabolism and immune
modulation. We will examine the genetic variation of B. fragilis strains from healthy and IBD cohorts. This
information will enable the construction of strain-specific B. fragilis genome-scale models to elucidate the
metabolic output and phenotypic states of IBD-associated strains. Next, we will determine the genetic
adaptations of B. fragilis in mouse models of colitis and test the impact of intestinal inflammation on bacterial
metabolism and immune modulation. Finally, we will examine how oxygen-adapted strains of B. fragilis may
have metabolic and immunological consequences on intestinal homeostasis. The proposed research is
significant because defining commensal bacteria adaptations to early stages of gut inflammation will be a
powerful strategy for detecting and treating early stages of IBD and preventing progression into the debilitating
chronic phase of IBD.

Public health relevance
PROJECT NARRATIVE The human microbiome has been implicated in numerous aspects of health and disease. The goal of this proposal is to determine the functional consequences of bacterial adaptation in the inflammatory intestinal environment. New insights into the contribution commensal bacterial adaptations to early stages of gut inflammation will be a powerful strategy for detecting and treating early stages of IBD and preventing progression into the debilitating chronic phase of IBD.